Defining molecular target of arsine gas-induced acute kidney injury and associated morbidity

Arsine (SA), the most toxic form of inorganic arsenic is a potent chemical warfare (CW) agent. Although arsine
was never used in the battlefield, concerns still exist that it may be used as a small-scale weapon during indoor
public meetings or concerts. None-the-less arsine exposure in occupational settings due to accidental release is
known among the industrial workers. Pathophysiology associated with inhaled arsine gas involves hemolysis of
massive red blood cells that often leads to kidney failure and associated morbidity/mortality. Erythrocyte
destruction leads to the release of hemoglobin (Hb) and heme into circulation, which subsequently accumulates
in the tubular epithelium, causing acute kidney injury (AKI). However, the detailed molecular mechanisms of its
toxic action are not fully defined and represent a major knowledge gap. Our preliminary data demonstrate that
arsine gas exposure at 15 ppm for 1 h to C57BL/6 mice induced intravascular hemolysis as evidenced by bloody
urine and dark red plasma, associated with a significant decrease in RBCs, hematocrit, and hemoglobin.
Additionally, a significant induction of NGAL and KIM-1, the early and late respective biomarker of AKI in urine
and kidneys were prominent. Utilizing an arsine-unrelated surrogate murine model of hemolysis, we show that
mice treated with phenylhydrazine (PHZ), a potent hemolytic agent, significantly causes hemolysis along with
an induction of AKI biomarkers, which is identical to that we observed in arsine gas-exposed mice. Thus, PHZ
mouse model provides critical utility to determine the pathogenic molecular underpinnings of arsine-mediated
hemolysis and associated kidney injury. Our preliminary data identified NOD1/2 as a key target in hemolysis-
mediated kidney injury in both of these mouse models. NOD1/NOD2 are immune response sensors and can
modulate inflammation and cellular injury. Two specific aims are proposed. In Aim-1, we propose to characterize
a mouse model of arsine toxicity. Both dose-and time-dependent responses will be characterized. Biomarkers
of AKI will be examined in urine, plasma/serum and kidney. Pro-inflammatory mediators will be examined in
serum and kidney. In addition, lung and liver damage will also be examined cursorily by histopathological analysis
to evaluate multi-organ damage by arsine exposure. This aim will help in selection of an optimum dose-and time-
point to develop medical countermeasures (MCM) for arsine toxicity. Aim-2 will define the therapeutic targets of
arsine toxicity. Here, we will first screen three NOD inhibitors for identifying the most efficacious nontoxic dose
employing PHZ mouse model. Then, one best NOD inhibitor (identified from PHZ model) will be tested for its
efficacy against arsine-mediated AKI and associated morbidity. Successful completion of studies proposed in
this R21 grant will provide a fully characterized mouse model and a novel molecular target-based therapeutic
drug agent as MCM against arsine. The efficacy of these MCMs against other surrogate hemolysis-related
disorders such as autoimmune hemolytic anemia, sickle cell disease, β-thalassemia, paroxysmal nocturnal
hemoglobinuria, hemolytic uremic syndrome etc. will help in getting faster FDA approval.

Public health relevance
Narrative Arsine gas is a powerful hemolytic poison. This R21 grant application aims to develop and characterize a murine model of arsine gas toxicity. Furthermore, this application will focus on the development of a novel molecular target-based inhibitor of arsine-induced acute kidney injury and associated morbidity.